DEVELOPMENT OF UNESTERIFIED CHOLESTEROL-RICH LIPID PARTICLES IN CULTURED CELLS

The purpose of this project is to explore the possibility that low density lipoprotein (LDL), once taken up by cells, can be degraded and transformed into unesterified cholesterol-rich lipid particles similar to those that we have previously identified and isolated from atherosclerotic lesions (see report Z01 HL 02826-07 EA). Two model systems, cultured fibroblasts from patients with type C Niemann-Pick disease (NPC) and livers of NCTR-BALB/c mice, were chosen for initial studies of cellular production and accumulation of unesterified cholesterol-rich lipid particles. Both models are autosomal-recessive lipid storage disorders with defects in intracellular cholesterol processing resulting in accumulation of unesterified cholesterol rather than esterified cholesterol the usual storage form of excess cellular cholesterol. Unesterified cholesterol-containing inclusions accumulate within cultured NPC fibroblasts during incubation with LDL. These inclusions appeared to be multilamellar liposomes with a hydrated density between 1.03 g/ml and 1.06 g/ml. The liposomes contained most of their cholesterol in an unesterified form (>90%) with a 1.5:1 molar ratio of unesterified cholesterol to phospholipid. NPC fibroblasts and normal fibroblasts incubated with lipoprotein- deficient serum plus LDL did not accumulate similar liposomes. This indicates that these unesterified cholesterol-containing liposomes were specifically derived from degradation of LDL and abnormal processing of cholesterol released from degraded LDL. Unesterified cholesterol-containing vesicles accumulated in livers of NCTR-BALB/c mice. These vesicles appeared to be uni- and multilamellar structures with a hydrated density between 1.04-1.07 g/ml. Most of their cholesterol was also in an unesterified form (>90%) with a 2.5:1 molar ratio of unesterified cholesterol to phospholipid. Studies carried out with both models should be helpful in elucidating the mechanism of formation of the unesterified cholesterol-rich lipid particles that accumulate within atherosclerotic lesions.